Identifying Optimal Antibiotic Treatment for Non-CTX-M-Producing ESBL Bloodstream Infections

Project Summary
Extended-spectrum β-lactamase-producing Enterobacterales (ESBL-E) bloodstream infections (BSI) are
associated with mortality upwards of 30%. It is unknown whether optimal antibiotic treatment differs based on
the type of ESBL enzyme produced. Most microbiology laboratories do not test bacteria for ESBL production,
opting instead to use non-susceptibility to third-generation cephalosporin antibiotics “3GCephNS” (e.g.,
ceftriaxone MIC ≥2 µg/mL) as a proxy for ESBL production. While this approach is pragmatic, it has hampered
progress in understanding the molecular epidemiology and targeted treatment strategies for ESBL families.
Our preliminary data suggest that 3 ESBL families account for ~99% of ESBLs: CTX-M (~60%), SHV-variants
(~25%), and TEM-variants (~15%). However, our understanding of optimal treatment of ESBL-E is limited to
CTX-M-producing infections. A resistance mechanism-based approach has been used to optimize antibiotic
treatment against carbapenemase genes (e.g., blaKPC, blaNDM), contributing to a ~200% reduction in mortality.
We believe a similar “precision medicine” approach should be investigated for treating ESBL-E BSI.
The need to characterize the type of ESBL produced is demonstrated by a clinical trial comparing outcomes of
patients with 3GCephNS BSIs receiving either piperacillin-tazobactam (PTZ) or meropenem. Mortality was
significantly lower for patients receiving meropenem. Meropenem was henceforth adopted as first-line therapy
for 3GCephNS BSIs (and by extension ESBL-E BSI). However, 87% of patients (no US patients included)
were infected with CTX-M-producing isolates. While CTX-M are the most common ESBL enzymes, they are
not the only ESBLs. It is unknown if meropenem is the preferred therapy for SHV and TEM ESBL variants.
There are differences in preferred substrates, inhibitors, and hydrolyzing abilities across ESBL enzymes. PTZ
may be effective treatment for BSI caused by specific ESBL families, as supported by our preliminary data. If
indeed, PTZ is a reasonable treatment option for certain ESBL-E families, then prescribing meropenem for all
ESBL-E infections without discrimination based on the type of ESBL family will only serve to fuel the crisis of
carbapenem-resistant Enterobacterales, without leading to improvements in patient outcomes.
Using a cohort of 2,000 consecutive 3GCephNS Enterobacterales BSI (diverse species) from 5 US hospitals,
we will characterize the epidemiology of β-lactamases. We hypothesize that blaCTX-M genes comprise ~60% of
β-lactamase genes. For ~40% of isolates, non-CTX-M ESBL genes (± ampC or narrow-spectrum β-lactamase
genes will be identified). Then, we will conduct an observational study to determine if patients infected with BSI
isolates producing non-CTX-M ESBL enzymes (i.e., SHV or TEM) have improved outcomes if receiving
meropenem vs. PTZ using a sophisticated inverse probability of treatment weighting approach incorporating
propensity scores. We hypothesize that PTZ will be effective treatment for ESBL-E caused by SHV and TEM
families given their reduced β-lactam hydrolyzing potential.

Public health relevance
Project Narrative The prevalence of extended-spectrum β-lactamase producing Enterobacterales (ESBL-E) has increased by over 50% in the US over a 5-year period - with upwards of 30% mortality associated with ESBL-E bloodstream infections (BSI). Our preliminary data across Enterobacterales species indicate that 3 ESBL gene families comprise ~99% of ESBLs (i.e., blaCTX-M [60%], blaSHV-variants [25%], and blaTEM-variants [15%]); however, little progress has been made to characterize the prevalence of non-CTX-M gene families across Enterobacterales species and it is unknown if piperacillin-tazobactam may be an effective carbapenem-sparing treatment option for SHV and TEM ESBL-E infections. We would like to investigate if a mechanistic-based treatment approach (i.e., optimal antibiotic treatment selection is dependent on the ESBL gene identified) will improve the outcomes of patients by (1) characterizing the epidemiology of ESBL genes in a multicenter cohort of 2,000 consecutive clinical Enterobacterales BSI isolates and (2) determining if meropenem is the preferred treatment for ESBL-producing Enterobacterales BSI regardless of the ESBL gene family present.